Imaging Mass Spectrometry-Based Metabolomic Analysis of the Alzheimer's Brain

IMAGING MASS SPECTROMETRY-BASED METABOLOMIC ANALYSIS OF THE ALZHEIMER'S BRAIN
PROJECT SUMMARY
Alzheimer's disease (AD) is the most prevalent neurodegenerative disorder. Although multiple genes and their
mutations linked to AD pathogenesis have been reported, the pathogenic mechanisms of AD still remain
elusive. The focus of the majority of AD research has been targeted towards the selective loss of specific
neuronal populations. Still, less effort has been spent in understanding reactive astrocytes, a feature common
to injury and disease in the aged brain. Recently, we described a subtype of reactive astrocytes that are
observed in various human neurodegenerative diseases, including AD and Parkinson's disease (PD).
Activation of microglia leads to the conversion of astrocytes into neurotoxic reactive astrocytes via secretion of
IL-1, TNF, and C1q. Blocking microglia activation with the drug, NLY01 prevented astrocyte conversion to
reactive astrocytes providing neuroprotection. The conversion of resting microglia and astrocytes to reactive
ones is deeply related to changes in energy metabolism and lipid composition in the cell. Resting microglia
mainly rely on oxidative phosphorylation for energy production. When microglia metabolism converts from
oxidative phosphorylation to glycolysis, microglia are activated. This change subsequently converts resting
astrocytes to reactive ones ramping up their glucose consumption. Long-chain saturated lipids in APOE and
APOJ secreted by astrocytes also have been reported to show neurotoxicity. Therefore, understanding
metabolomic changes in microglia, astrocytes, and neurons during the course of neurodegeneration is likely to
provide a deeper understanding of AD pathogenesis. Imaging mass spectrometry-based metabolomic analysis
will provide a view of cell-type and region-specific metabolomic changes in the brain. To study metabolomic
changes in a cell-type-specific manner, we propose three specific aims. (Aim 1) We will examine region- and
cell-type-specific metabolomic changes in the microglia-astrocyte-neuron axis in the brain of mice
overexpressing amyloid β and in response to pathologic tau. (AIM 2) We will examine region- and cell-type-
specific metabolomic changes in control and AD human post-mortem brains. (Aim 3) We will compare region-
and cell-type-specific brain metabolomic changes of mice overexpressing amyloid β and in response to
pathologic tau with the ones lacking microglial activation by the treatment with PLX3397 or NLY01. The
completion of these aims will provide a better understanding of cell-type metabolome dynamics during aging
and neurodegeneration mediated by overexpressed amyloid β and pathologic-tau injection. The novel
information acquired in this study will provide indispensable insights into cell-type-specific AD pathogenic
mechanisms and offer new opportunities to develop new AD treatments targeting microglia and astrocytes.
Furthermore, this strategy can be expanded to study the pathogenesis of other brain diseases.
1

Public health relevance
PROJECT NARRATIVE This study will provide a comprehensive metabolomic landscape on the cell-type specific metabolomic changes during aging and the process of neurodegeneration when the brain is exposed to pathologic amyloid β and pathologic tau. This information will provide opportunities to develop new AD treatments targeting microglia and astrocytes. 2